Training to Enhance Alignment of Psychiatry and Neuroscience

SUMMARY
This postdoctoral training program at McLean Hospital is designed to address gaps in psychiatry and
neuroscience training that limit effective communication across disciplines and translation of discoveries into
new treatments. In psychiatry, rapid advances in technology are changing the ways in which psychiatric illness
is diagnosed, treated, and studied. In humans, continued refinements in brain imaging, increasing utilization of
smart devices, and improvements in the efficiency of genetic tools are among developments enabling
fundamentally new insights into healthy and aberrant brain function, as well as molecular factors that contribute
to vulnerability to illness. In animal model systems, there has been a corresponding evolution of precision
molecular techniques to probe and dissect the neural circuitry underlying motivational and emotional behavior.
Despite these advances, psychiatry and neuroscience continue to evolve in parallel, with precious few examples
where the fields have aligned to produce transformative changes in human health. One indicator of this parallel
evolution is stagnation in development of new treatments; indeed, difficulties in developing CNS drugs with new
mechanisms have led to a massive divestment by industry. While many factors contribute to these failures, most
are related to a lack of forward- (animal to human) and back- (human to animal) translation of key discoveries,
leading to questions about the usefulness of model systems in drug development. Enhancing alignment of
psychiatry and neuroscience is critical to invigorate translationally-relevant discoveries in clinical and basic
research. With its combined clinical, research, and academic missions, McLean is optimally positioned to play
a key role in establishing more impactful interactions between psychiatry and neuroscience. Research occurs
in >100 labs across clinical, preclinical, and basic neuroscience programs that are intertwined, in adjacent labs
or neighboring buildings, enabling routine interactions among clinicians, neuroscientists, and trainees (residents,
postdocs, students). As a freestanding psychiatric hospital—perennially ranked #1 in this category—there is
expertise in a broad range of NIMH-relevant domains. McLean has unique attributes, including the Institute for
Technology in Psychiatry, to facilitate efforts to align research in humans and animals. This T32 program will
provide resources for 6 slots per year to support activities for postdoctoral trainees across a range of experience
levels for up to 3 years. The main objectives include (1) exposing a diverse group of trainees with backgrounds
in clinical care to basic neuroscience research, and vice-versa, (2) providing comprehensive training that
prioritizes emerging technologies such as digital phenotyping, biomarkers, and genetics to enable rigorous study
of homologous endpoints in humans and animals, (3) ensuring a balanced experience via dual mentors with
complementary expertise, and (4) leveraging the dual mentorship design to train emerging mentors. Progress
towards these goals will be overseen by a McLean leadership team and an External Advisory Committee
comprising world-renowned experts in psychiatry, neuroscience, training, and therapeutics development.

Public health relevance
NARRATIVE Despite decades of major advances in the ability to study the brain processes that control behavior, we have not yet reached the goal of translating this new knowledge into breakthroughs in treating psychiatric illness. Progress has been limited by the fact that few researchers have a combined understanding of psychiatric illness as it appears in humans and how it is studied in laboratory models, which limits effective communication across disciplines and translation of discoveries into treatments. This McLean Hospital training program is designed to ensure that postdoctoral trainees develop a sophisticated understanding of both psychiatry and neuroscience by utilizing specialized mentorship teams with expertise that covers both disciplines.